Feeling and Body Investigators (FBI)-ARFID Division: Sensory and Somatic Exposure for Children with Avoidant Restrictive Food Intake Disorder

Avoidant Restrictive Food Intake Disorder (ARFID) is a newly articulated eating disorder in the DSM-5 in which
individuals are not able to consume an adequate quantity or variety of food to sustain healthy growth and de-
velopment. ARFID typically onsets in early childhood, yet identification of the disorder is poor. The end result is
that children often have sustained inadequate nutrition with resulting severe physical consequences and
threats to optimal social and emotional development. Early intervention is essential. However, there are no em-
pirically validated treatments for young children with ARFID. Children with ARFID are known to be sensitive
individuals: with a low threshold for noticing internal body sensations (e.g., gastrointestinal distress) and exter-
nal sensory sensations (e.g., smells) and experiencing these sensations as uncomfortable/aversive. This sen-
sitivity, and the associated negative emotional reactions (e.g., of disgust, fear, sadness), may encourage
avoidance of activities that cause these sensory experiences, such as eating. An intervention that could
change reactions to sensory and somatic sensations to one of playful curiosity may increase approach behav-
ior and food consumption. We designed an acceptance-based interoceptive exposure treatment for children to
achieve this goal. We teach children and caregivers to be “FBI Agents,” individuals who view somatic and sen-
sory sensations as clues to a mystery via the use of engaging illustrative cartoon characters (e.g., Gassy Gus),
body investigations that provoke intense sensations and worksheets that map sensations to meanings and ac-
tions. The goal is to make somatic and sensory experiences playful – and to promote adaptive self-awareness
and food approach. The overall objective of this study is to determine whether treatment results in reduced
negative emotions to somatic and sensory sensations, including those associated with food and eating, and
whether this, in turn, increases food approach. This will be accomplished by a randomized controlled trial (N =
140, 70 per cell) comparing The Feeling and Body Investigators (FBI) - ARFID Division treatment, a 20-session
outpatient treatment, to a control group in children (5 to 9 years of age) with ARFID. The control treatment
(FAD: Family-Assisted Diet) will provide family-supported exposure. Our proposed mediator of treatment re-
sponse is negative affect: a child’s facial affect in response to food presentation as measured via smartphone
videos. Outcomes include changes in anthropometric measurements, nutrition variety and adequacy, and psy-
chosocial functioning. Medical and psychological measurements will be assessed pre- and post-treatment, at
every session, and 3-month follow-up. Deliverables include an empirically validated treatment(s); medical
guidelines for the early detection of insufficient nutrition; practical tools for assessing food acceptance in the
home via smartphones; and guidance about the number of food presentations necessary to facilitate
acceptance. Ultimately, we will evaluate this treatment and disseminate materials via primary care to provide
tools to intervene early on food avoidance.

Public health relevance
Avoidant Restrictive Food Intake Disorder (ARFID) is a disorder in which individuals are not able to consume an adequate amount or variety of food to a degree that it affects their growth. The goal of this project is to compare 2 treatments and see which one (or both) is effective in treating ARFID in children. As a result of this project, we will have tested treatments for children with ARFID; developed medical guidelines for the early detection of insufficient nutrition; developed practical tools for assessing food acceptance in the home via smartphones; and have acquired practical guidance about the number of times parents need to present food to get their child to like it.